Admin Core

SUMMARY
The Administrative Core (Core A) will serve as the hub of the proposed NIAID PPG entitled “The Role of
Senescent Cells in Dysregulating Immune Response and Pathogen Control” comprised of three research
projects and two research resource Cores (Cores B and C). The PIs of Core A are Dr. Stephen Jameson,
Professor in the Department of Laboratory Medicine and Pathology at UMN and an expert in adaptive immune
responses to pathogens, and Dr. Laura Niedernhofer, Director of the Institute on the Biology of Aging and
Metabolism (iBAM) at UMN, an expert in cellular senescence and mouse models of accelerated senescence
and aging. Both have led and/or been involved in several NIH P and U series grants. Overall, this PPG will
examine the effect of age and increased senescent cell (SnC) burden on immune function. To do so, we propose
an interdisciplinary approach combining the expertise of leaders in the fields of the biology of aging and
immunology, leveraging the synergies provided by these interactions coordinated around two Scientific Cores
(one for sophisticated transgenic models and pathogen exposure paradigms, the other for complex single-cell
and spatial analysis of tissues). The overall goals of the Administrative Core A will be to ensure this team is
working effectively together by providing general scientific, programmatic and fiscal leadership, and by facilitating
lines of communication between the three projects and two research cores. The Core A will maintain the
cohesiveness and coherence of the program and long-range goals to ensure that resources resulting from the
research will benefit the scientific community. As senior scientists, the PIs of Core A will also foster the career
development of the early-stage faculty in the Program as well as trainees in all Projects and Cores. The Specific
Aims of Core A are to: 1) Plan and coordinate the proposed research activities of the PPG, monitor progress,
and ensure sound fiscal and resource management in compliance with NIH regulations; 2) Ensure regular and
thorough internal and external evaluation of scientific quality and guarantee continued progress of the research
of the PPG; 3) Working with the other cores, organize and prioritize the exchange of personnel, information,
reagents, cell, tissues, and mice among the different projects and cores and to mobilize new tools, technology
and data resources to help the PPG researchers efficiently accomplish their goals and disseminate their results
to the broader scientific community in a timely fashion; 4) Coordinate the interactions between Research Projects
and Cores.